Defining the Mechanistic Basis of Bacterial Androgen Production in Dampening Anti-Tumor Immunity and Promoting Resistance to Androgen Receptor Axis-Targeted Therapies for Metastatic Prostate Cancer

Project Summary/Abstract
There is increasing evidence over the past decade that the composition of the gut microbiome is important for
cancer therapy effectiveness including chemotherapy, endocrine therapy, and immune therapy. In fact,
modulation of the microbiome is in clinical trials to enhance immunotherapy clinical responses in multiple solid
tumors. Despite the explosion of studies on the microbiome-cancer therapy axis, relatively little is known about
the mechanism(s) utilized by gut microbiota to shape therapy response or resistance. In metastatic castration
resistant prostate cancer (mCRPC), the deadly form of the disease, intra-tumoral androgens likely mediate
immunotherapy and endocrine therapy resistance. Collectively, the three PIs of this application have 1) identified
and characterized the only known human-associated bacterial genes capable of converting glucocorticoids into
non-conventional androgens; 2) collected and sequenced a 5-year microbiome biorepository from individuals
with advanced prostate cancer taking oral androgen axis-targeted therapy; and 3) demonstrated that response
to immunotherapy in advanced prostate cancer requires androgen receptor inhibition on T cells. Working
together, we provide evidence that species of the gut microbiome produce androgen metabolites that act as
ligands for the androgen receptor. This observation underscores our clinical observation that the gut microbiome
of endocrine therapy or immunotherapy sensitive versus resistant patients is distinct and significantly unique.
We propose that androgen metabolism by the gastrointestinal (GI) microbiota serves as a unique source of
tumor-associated androgens that promote endocrine and immune therapy resistance. We propose the following
aims: Aim 1: Define the functional significance of microbial-derived androgens on immunotherapy effectiveness.
We will determine if microbial-derived androgens are sufficient to mediate therapy resistance and how these
metabolites regulate murine and human T cell function. Aim 2: Determine the GI microbial gene pathways and
androgen metabolites that are determinants of therapeutic response and resistance in mCRPC. These studies
will identify novel bacterial species and genes associated with endocrine and immunotherapy resistance. Aim 3:
Evaluate the impact of microbial-derived androgen production on tumor intrinsic growth, MHC I expression, and
abiraterone acetate/prednisone resistance. We will evaluate the cause-and-effect relationship between microbial
metabolism of androgens and endocrine therapy resistance. Cumulatively, these studies provide a mechanistic
understanding of how the human microbiome promotes endocrine resistance and inhibits anti-tumor immunity
and provide novel microbiota-associated therapeutic targets to reduce androgen-mediated immune suppression.

Public health relevance
Metastatic castration resistant prostate cancer (mCRPC) remains a leading cause of cancer deaths in males and there is a tremendous unmet clinical need to uncover mechanisms of therapeutic resistance in this patient population. This study will discover and validate bacterial enzymatic pathways that are responsible for androgen production in the gut that contributes to therapeutic resistance to immunotherapy and endocrine therapy in mCRPC. We ultimately aim to identify a microbiome drug target for use in the development of targeted therapeutics to overcome treatment resistance; as such, we anticipate that the knowledge gained from the proposed studies could be translated to a therapeutic that could greatly impact the lives of individuals with advanced mCRPC.